The Genetics of Impulsivity and Motivation

––– PROJECT SUMMARY/ABSTRACT ––––––––––––––––– The Genetics of Impulsivity and Motivation –––
One way to isolate novel genes contributing to addiction is to focus on endophenotypes, more circumscribed
biological and behavioral markers well-correlated with the substance use disorder (SUD). Impulsivity, making
rash decisions and ‘bad’/costly choices, and motivation, the impetus for goal-directed behavior and the
willingness to incur effort or cost to reach said goal, are key behavioral domains that are common to all SUDs,
but their genetic underpinnings are poorly understood. The vinegar fly, Drosophila melanogaster, has been a
genetic model organism for more than a hundred years. Major strides have been made in the last 15 years
studying the behavioral responses to alcohol and other drugs of abuse in flies, both in characterizing novel
conserved genes and pathways, but also in the development of new assays that resemble endophenotypes of
addiction more closely. The goal of this proposal is to isolate, validate, and functionally characterize genes that
affect a novel model of impulsivity and motivation. In our newly developed Fly Liquid-food Electroshock Assay
(FLEA), Drosophila choose between two wells of liquid food that are paired with two distinct electroshocks,
allowing us to ask whether flies prefer high shock/high sucrose, or low shock/low sucrose. Importantly, when
flies are food deprived, they change their relative valuation of shock/sucrose and prefer the high shock/high
sucrose. Commonly used animal models for impulsivity, e.g. the delay discounting task, are insensitive to
deprivation. Conversely, humans do act more impulsively when deprived, e.g. shifting towards a smaller drug
dose now, rather than a larger ‘hit’ later. Therefore, our novel FLEA assay models some important aspects of
human impulsivity that are highly relevant for SUD. We will combine the economy of scale of Drosophila with
the unique face validity of our innovative FLEA assay to illuminate the genes and variants that underlie impulsivity
and motivation to 1) determine the role M6 plays in impulsivity and motivation. M6 is the fly ortholog of the human
candidate impulsivity gene GPM6B. 2) We will perform a GWAS with ~200 fully sequenced Drosophila lines,
giving us unprecedented insight into variants and genes that affect impulsivity and motivation. This will serve to
seed new avenues of research to investigate the function and circuitry regulating impulsivity and motivation. We
will also test candidate genes from these Aims in our just developed assays measuring experience-dependent
amphetamine or cocaine preference. Our proposal is therefore fully compatible with the Cutting-Edge Basic
Research Award (CEBRA) which is “not intended for incremental research or research extending ongoing
programs”, but rather “this announcement encourages applications from investigators with experience in SUD-
relevant research who wish to explore and develop new methods, techniques or conceptual frameworks to study
basic questions in this research area” (PAR-21-208).

Public health relevance
––– PROJECT NARRATIVE –––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––– Substance use disorders are a chronic human condition where initial consumption leads to long-lasting behavioral changes that are fueled by impulsive choices and changes in motivation, chiefly an increased desire for the abused substance. Substance use is also driven by genetic factors, but what genes underlie impulsivity and changes in motivation are largely unknown. The results from this proposal will isolate genetic factors affecting impulsivity and motivation, thereby illuminating critical mechanisms driving addiction and substance use.